Mixed Chimerism-Dependent Tolerance After Myeloablative Bone Marrow Transplantation

Graft-versus-host disease (GVHD) is a lethal and devastating complication of hematopoietic cell
transplantation (HCT) or bone marrow transplantation (BMT), where HCT/BMT constitutes a predominant and
curative approach for the treatment of hematological malignancies and other disorders. Because of exposure
to environmental agents, such as the carcinogen agent orange, members of the US Military are under risk to
develop hematological malignancies during their years as active soldiers or later as veterans. GVHD is caused
by donor (graft) T cell-mediated immune attack of recipient (host) tissues and also complicates the clinical
picture after combined transplantation of bone marrow and a solid organ. Veterans are also under higher risk
to develop end-stage solid organ failure that requires transplantation. Novel treatment strategies are needed in
BMT/HCT patients to maintain the donor T lymphocyte-mediated anti-tumor immune (graft-versus-tumor (GVT)
response and suppress the GVHD. In this context, therapeutic achievement of mixed chimerism, which is
characterized by the presence of donor and recipient hematopoietic cell after transplantation, results in
immune tolerance by donor T cells against the recipient and in regulation of GVHD. Mixed chimerism also
tolerizes recipient’s immune cells against the donor, suppressing the rejection of solid organ graft after
combined transplantation and reduces the use of toxic immune suppressive medications. Current clinical
protocols mostly use nonmyeloablative preparation (lower dose of chemotherapy and/or radiation without
completely eradicating recipient’s bone marrow cells) before the BMT/HCT to achieve mixed chimerism. This
approach carries a high risk of tumor relapse. By contrast, we use myeloablative preparation (higher dose of
chemotherapy and/or radiation with complete eradication of recipient’s bone marrow cells) in our BMT model
with mixed chimerism, where the GVT response is preserved and the risk of cancer relapse is reduced. We
induce mixed chimerism-dependent regulation of GVHD by modulation of intestinal immune pathways using a
completely novel approach and with self-limited helminth colonization of the gut. We have shown before that
helminths promote the generation of mixed chimerism by stimulating recipient cell Th2 signaling and Th2-
dependent generation of TGFβ. In this application, in Aim #1 we propose to investigate the elements of
Th2/TGFβ pathways critical to generation of mixed chimerism. In Aim #2, we will explore the role of different
immune regulatory circuitries relevant to mixed chimerism-dependent regulation of GVHD and solid organ
rejection. In Aim #3, we will investigate the effect of mixed chimerism-induced immune regulation on the GVT
response using a mouse leukemia/lymphoma model syngeneic with the BMT recipient strain. Our long-term
goals are to dissect immune regulatory pathways important in helminth-induced mixed chimerism and apply
the knowledge to clinical transplantation. Live helminths have been safely administered to immune suppressed
patients, and helminth products with immune regulatory properties have been discovered for potential use in
clinical practice. Therefore, targeting helminth-modulated signaling pathways with small molecules, helminths
or their products may be a safe, potent and novel approach to promote transplantation tolerance without using
toxic immune suppressive medications and preserve the beneficial GVT effect.

Public health relevance
The U.S. Veterans are under risk to develop lethal blood cancers due to exposure to carcinogens, such as agent orange, during their active military service. Many of these cancers are treated with hematopoietic cell transplantation (HCT) or bone marrow transplantation (BMT), where the successful outcome of transplant procedure is curtailed by the devastating and lethal graft-versus-host disease (GVHD). The US Veterans are likewise under risk to develop end-stage organ failure (such as kidney failure), where successful treatment with organ transplantation is curtailed by rejection. GVHD or rejection of a solid organ can be prevented without the use of toxic immune suppressive medications by inducing a condition called mixed chimerism, which is characterized by the presence of recipient and donor blood cells after transplantation. Our studies are expected to lead to the identification of novel, safe and potent therapeutic approaches to treat Veterans against GVHD or organ rejection by stimulating mixed chimerism, while preventing the relapse of the cancer.